BIOACTIVE MEDIATORS IN ASTHMA

The purpose of this study is to determine the mechanism by which two bioactive mediators, leukotriene (LT) D4 and platelet activating factor (PAF), increase nonspecific airway reactivity in normal subjects. The particular focus is on the role alveolar macrophages play in these events.